Esomeprazole counteracts chlorine toxicity in pregnant animals

We have shown that pregnant mice are particularly susceptible to injury caused by Br2 exposure and develop
symptoms that are reminiscent of preeclampsia. We identified placental production of a short splice variant of
FMS-like tyrosine kinase 1 (sFLT-1) and consequent inhibition of signaling via vascular endothelial growth factor
(VEGF) as an underlying mechanism. Additionally, treatment with the type V phosphodiesterase inhibitor
(PDE5i) tadalafil or treatment with recombinant VEGF mitigate pregnancy-specific Br2 toxicty by reducing blood
pressure, restoring heart function, reducing respiratory and metabolic acidosis and reducing lung edema. In
preliminary data, we demonstrate that Cl2 exposure is highly toxic to pregnant mice, resulting in severe maternal
weight loss, high rate of maternal mortality and severe fetal growth restriction. Additional preliminary data show
that treatment with the proton pump inhibitor (PPI) esomeprazole (ESO; 30 mg/kg/day by gavage), which is the
active ingredient of Nexium®, results in improved maternal weight gain and fetal growth in Cl2 exposed pregnant
mice. ESO is a PPI, but was found to stimulate nuclear factor (erythroid-derived 2)–like 2 (Nrf2), resulting in the
increased expression of antioxidant genes including HO-1 as well. HO-1 is critical for the development and
maintenance of normal pregnancy. Stimulation of HO-1 expression has been shown to antagonize mechanisms
that cause preeclampsia and ameliorate diagnostic signs of preeclampsia in animal models. Our specific aims
were designed to test the hypothesis that ESO (30 mg/kg/day by gavage) improves survival and fetal growth by
inducing HO-1 via activation of nuclear factor (erythroid-derived 2)–like 2 (Nrf2) and the protective effects will be
accompanied by reduced mediators and symptoms of preeclampsia that occur in Cl2 exposed pregnant mice.
To test these proposed mechanisms, we will compare the efficacy of ESO to another, FDA-approved Nrf2
activator dimethyl fumarate (DMF; Tecfidera®) and we will assess the effects of the chemical inhibitors of Nrf2
(ML385) and HO-1 (tin proto porphyrin IX; SnPP) on the efficacy of ESO. SA#1: To compare the efficacy of
ESO (30 mg/kg/day by gavage) with DMF (100 mg/kg/day by gavage) to reduce maternal mortality, fetal
growth restriction and symptoms of preeclampsia in Cl2 exposed pregnant mice. DMF is an FDA approved
drug for the treatment of multiple sclerosis. Similar to ESO, DMF is known to activate Nrf2, but it is not a proton
pump inhibitor. Comparing the efficacy of ESO to DMF will allow to dissociate the mechanistic contribution of
Nrf2 activation from the PPI function of ESO. SA#2 To test the mechanistic roles of Nrf2 activation and HO-
1 activity in protection from Cl2 exposure toxicity by ESO. We will use the small molecule inhibitors of Nrf2
(ML385) and HO-1 (tin protoporphyrin IX; SnPP) for mechanistic testing. Success of this research plan will be
the basis of a full application (UO1) for the testing of dose-dependent efficacy of ESO and/or DMF against both
Cl2 and Br2 induced pathology in pregnant mice, including the continuous monitoring of blood pressure with
telemetry, and additional mechanistic studies using Nrf2 and HO-1 gene-targeted murine models.

Public health relevance
In preliminary data for this application, we demonstrate that Cl2 exposure highly toxic to pregnant mice, resulting in severe maternal weight loss and severe fetal growth restriction even at a very low exposure level (400 ppm for 10 minutes), which causes minimal damage and no deaths in non-pregnant mice. Additional preliminary data show that treatment with esomeprazole (ESO; 30 mg/kg/day by gavage), which is the active ingredient of Nexium®, results in improved maternal weight gain and survival, as well as improved fetal growth in Cl2 exposed pregnant mice. This exploratory and developmental project is designed to test the basic tenets of this hypothesis and to lay the foundation for a subsequent full UO-1 proposal designed to fully and mechanistically test the aforementioned hypothesis.